Administrative Core

Core A Aims: Administrative

Aim 1. Continuously improve and implement an ongoing strategic plan for shaping, expanding, and optimizing diabetes-related translation research and promoting health for all and improving diabetes outcomes at Emory University, Georgia Tech, Morehouse School of Medicine, and its affiliated regional partners. Rationale: A well-thought out and executed strategic plan is crucial for effective promotion and dissemination of diabetes-related translation research. Key Core A activities that support this aim include:
• Convening Internal and External Advisory Committee meetings that provide strategic planning assistance to the GCDTR leadership and helps promote the GCDTR through their own networks.
• Facilitating an annual strategic planning process that assembles input from GCDTR users, Directors, Experts, Members, and Advisory Committee members.
• Engaging Associate Directors dedicated to improving population health across all cores and programs.

Aim 2. Provide oversight and direction, monitor progress, and promote growth for all GCDTR programs and Translation Cores. Rationale: Implementing a synergistic, coordinated program for advancing diabetes translation research requires administrative direction and oversight. GCDTR’s effectiveness depends on its ability to use resources wisely, meet its goals, and as necessary, adapt Center goals as research questions, challenges, opportunities, and support needs evolve. Key Core A activities that support this aim include:
• Managing program funding, including reconfirming or revising, on an annual basis, the set of Translation Research Cores and activities that will receive GCDTR support. Approving and monitoring staffing, services, consultation, and training activities conducted through the Translation Cores, the Regional Core, the Pilot and Feasibility (P and F) Program, and the Enrichment Program.
• Providing strategic and administrative leadership to GCDTR outreach, recruitment, and retention activities including the Regional Core, P and F Program, and the Enrichment Program.
• Monitoring progress and adherence to GCDTR goals, enhancing the center’s mission of health for all, making mid-course adjustments as needed.
• Gathering feedback from GCDTR members annually to improve services and other offerings.
• Convening Executive Council (Translation Research Core and Program Directors) meetings monthly.
• Implementing an annual formative review of all Cores and Programs that includes: meetings with each Core for evaluation and strategic planning; biennial meetings with the Internal Advisory and External Advisory Committees for an objective assessment of Center plans, activities, progress, and strategic planning; and adding activities and/or making mid-course corrections, as needed.
• Reporting status and progress to NIDDK.

Aim 3. Promote interactions and communication between GCDTR member, affiliate, and collaborating institutions across Georgia and the Center’s regional partners. Rationale: Enabling interdisciplinary interactions, collaborations, and effective communication promotes cohesion, creativity, and productivity. Key Core A activities that support this aim include:
• Providing planning, funding, administrative support, and oversight for GCDTR activities focused on promoting and enriching the research base in diabetes translation, including:
o The GCDTR website, overall Center and Core listservs, and a quarterly electronic newsletter;
o Enrichment Program meetings and activities; and
o Linking GCDTR activities with regional and national programs (e.g., NIDDK’s CDTR program website).
• Working with the Enrichment Program, P&F Program, and Cores to arrange Expert linkages and mentoring for junior or new faculty and fellows.
• Supporting communication for the Regional Core to build and maintain relationships, disseminate, and facilitate translation research, and market GCDTR core resources.